Targeting PKR-Bcl2 Signaling to Overcome Paclitaxel Resistance in Ovarian Cancer

Abstract Text
Many antitubulin agents, such as paclitaxel (Taxol), have been used extensively for treatment of
several types of cancer, including ovarian, lung, pancreatic, and breast cancers. Despite their
wide use in cancer treatment, however, patient response is highly variable and drug resistance
remains a major clinical issue. It is therefore essential to identify prognostic markers to predict the
patient response and to enhance drug sensitivity. Protein kinase R (PKR) plays significant roles
in innate immune response to viral infection and tumorigenesis. The biological significance of PKR
in antitubulin chemotherapeutics and underlying mechanisms have yet to be defined. Through
Phos-tag-based kinome-wide biochemical screens, we identified PKR as a critical regulator in
antitubulin cytotoxicity. Our preliminary data suggest that inactivation of PKR confers resistance
to Taxol in ovarian and breast cancer cells. Enhanced expression of PKR potentiates taxol
cytotoxicity in vitro and in vivo. We further identified novel phosphorylation sites on PKR during
antitubulin-mitotic arrest and in normal mitosis. Mechanistically, our findings also suggest that
PKR controls Taxol chemosensitivity through modulating Bcl2 expression. Our hypothesis is that
the PKR-Bcl2 axis functions as a therapeutic target for antitubulin agent-based
chemotherapeutics in treatment of drug-resistant and/or recurrent patients. We will test our central
hypothesis by three specific aims. Aim 1: Examine the functional significance of PKR in antitubulin
chemotherapeutics in vivo; Aim 2: Determine how antitubulin drugs regulate PKR; Aim 3:
Elucidate the mechanisms and downstream signaling of PKR in antitubulin chemosensitivity. The
identification of new regulators and/or signaling pathways triggered by antitubulin drugs will shed
light on the mechanisms underlying chemoresistance. Our study suggests that combining kinase
activators (e.g., being characterized in this application) for PKR or Bcl2 inhibitors (FDA-approved)
with antitubulin agents will have enhanced efficacy in treatment of drug-resistant and/or recurrent
patients. Our findings also suggest that profiling PKR-Bcl2 signaling status of tumors
(mRNA/protein levels and activity) can be useful to predict the patient response to antitubulin
chemotherapeutics.

Public health relevance
Narrative The identification of new regulators and/or signaling pathways triggered by antitubulin drugs will shed light on the mechanisms underlying chemoresistance. Our study identifies PKR as a critical regulator of paclitaxel chemosensitivity. Targeting the PKR-Bcl2 axis is expected to have enhanced efficacy in the treatment of paclitaxel-resistant and/or recurrent ovarian cancer patients.